Novel non-narcotic analgesic for acute and chronic pain

Abstract
Acute and chronic pain affect more than 50 million Americans and there is an enormous unmet need for safer
pain relief. Although acetaminophen (ApAP) is among the medicines most commonly used for pain relief,
hepatotoxicity is a risk and overdose is the most common cause of acute fulminant hepatic failure. Oxidation of
ApAP to N-acetyl-p-benzoquinone imine (NAPQI) leads to hepatotoxicity. We synthesized ApAP analogues
bearing a heterocyclic moiety linked to the p-acylaminophenol fragment, and analogs to its metabolite were then
created to further enhance the safety profile (eliminating liver and kidney toxicity) while retaining analgesia and
antipyresis. Liquid chromatography tandem mass spectrometry demonstrated no NAPQI formation in mice after
intraperitoneal or oral administration of toxic doses of these new chemical entities while NAPQI was formed in
the liver of ApAP-treated mice. Immunostaining for nitrotyrosine, a mitochondrial free radical marker, was
observed in liver from ApAP-treated mice but not in mice treated with the new chemical entities. Moreover, the
integrity of hepatic tight junctions, another hallmark of ApAP-hepatotoxicity, was lost in mice after high doses of
ApAP, but not in mice treated with these new chemical entities. Next, extensive proof of concept studies using
different in vivo analgesia assays (von Frey, cold tail flick and abdominal writhing) and in vivo anti-pyretic models
(LPS- and Baker’s yeast) led us to a lead compound for pre-clinical development, SRP-3D (diethylamide [DA]).
To date, we have completed the following IND-enabling studies for SRP-3D (DA): 1) scale synthesis of 1kg
cGMP, 2) establishment of bioanalytical methods, 3) characterization of the cytochrome P450 isoenzyme profile,
4) demonstration of the lead compound’s stability and metabolites in human hepatocytes, and 5) confirmation
that it is not mutagenic (Ames test). Taken together the results of these IND-enabling studies support the
following Specific Aims for this STTR-HEAL Fast-Track project. Specific Aim 1: Demonstrate the feasibility
for drug development of SRP-3D (DA); Specific Aim 2: Determine the most effective oral and intravenous
formulations of SRPs-3D (DA) for both chronic and acute pain indications; and Specific Aim 3: Further
de-risk development toward an IND submission by completing GLP-toxicology. Our proposed studies also
include defining analgesia profile in gender and during aging. These Aims will be a decisive step in
commercialization of SRP-3D (DA) to treat acute and chronic pain safely. Given the widespread use of ApAP,
the risk of hepatotoxicity with overuse and the ongoing opioid epidemic, this new chemical entity represents a
novel non-narcotic analgesic without hepatotoxicity.

Public health relevance
Project Narrative Acute and chronic pain management is one of the most prevalent and costly public health issues worldwide. Current medications are either highly addictive or cause harm to the liver and kidney with overuse or abuse. In this HEAL STTR Fast-Track project application, we describe a new class of non-opioid small molecules devoid of the potential for abuse. In pre-clinical studies, our lead molecule reduced pain without the liver and kidney toxicity associated with current common over-the-counter analgesics.